Retinal Mitochondrial Metabolism in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is the leading cause of dementia. Effective treatment and tests for early diagnosis
are still not available. AD patients often have ocular pathology occurring before the onset of neurological
symptoms. Multiple lines of evidence show that altered metabolism is the underlying mechanism for AD. We
recently found that there are early and common changes in metabolites associated with mitochondrial
metabolism within brain and eye tissues in an AD mouse model harboring three common human mutations.
Our findings strongly suggest that studying metabolic changes in the eye of early AD could be promising to
develop an earlier diagnosis for AD. The long-term goal of this project is to identify the metabolic signature of
eye tissues compared to the brain in the early stage of AD to develop new early biomarkers and to reveal the
biochemical basis of AD. We plan to rigorously investigate the changes of metabolome using state-of-the-art
technologies, including targeted metabolomics and metabolic flux analysis.
The outcome of this research will provide early metabolic biomarkers in the eye and brain in preclinical AD,
reveal the metabolic flux in mitochondrial metabolism in early AD. As the eye is easily accessible, the findings
of this proposal will provide a strong foundation to develop novel strategies for early detection and potential
targets for early intervention.

Public health relevance
NARRATIVE We have found early and common metabolic changes between eye tissues and the brain in an Alzheimer's Disease (AD) animal model. The findings of this proposal will provide a strong foundation to develop novel strategies for early detection and targets for early treatment of AD. 1